Genomic and Computational Biology Support for NIDCD Intramural Research

In FY25, the GCBC worked with 20 different principal investigators from the NIDCD and NIDCR on more than 40 separate projects. These included RNA-seq at both single cell and tissue level, spatial RNA-seq, long read IsoSeq, whole-exome and whole-genome variant detection and epigenetic (ATAC-seq and ChIP-seq) studies. These projects encompassed mouse models of disease, viral vectors for gene therapy and human subject DNA and RNA. In all projects the GCBC participated in experimental design, library production, sequencing and the bioinformatic analyses of the data. In addition, the GCBC helped to deposit data in public repositories when appropriate, and aided researchers in retrieving and analyzing publicly available genomic data.